Administrative Core

Project Summary/Abstract – Administrative Core
Boise State University has established a Center of Biomedical Research Excellence in Matrix Biology during
Phase I. The thematic focus of matrix biology has allowed researchers to address some of the most
challenging health concerns facing our nation. To date, this centralized mechanism has supported sixteen
junior investigators, seven as Research Project Investigators and nine at the Pilot Investigator level. The center
has allowed us to capitalize on the broad, diverse research base that exists at Boise State University. In Phase
II, we propose to enhance and grow the COBRE in Matrix Biology program by building upon the programmatic
infrastructure that was established in Phase I through the Administrative Core. The primary goals of Phase II of
the COBRE in Matrix Biology are to support investigators, to enhance the productivity of junior, mid-career, and
established scientists, to facilitate collaboration between both junior and established researchers, and to build
biomedical research infrastructure at Boise State University. Major programmatic emphases of the COBRE in
Matrix Biology are to support the analysis of animal models of relevance to cell-extracellular matrix interactions
in disease progression and tissue repair/regeneration and to provide access to research instrumentation and
technical support. Through the Administrative Core, the COBRE in Matrix Biology will sponsor career
development of junior investigators, the establishment of new collaborations between investigators, activities
that will promote the exchange of information, ideas and reagents between COBRE members. We will continue
to grow the center by recruiting non-members who are doing meritorious research within the thematic focus of
the COBRE in Matrix Biology. The Administrative Core will continue to offer a pilot project program as a
recruitment tool to provide funding to young and to established investigators who propose to apply their
expertise to matrix biology.